Predoctoral Training Program in Microbial Pathogenesis

ABSTRACT
This application is a request for continuation of support for a pre-doctoral training program in Microbial
Pathogenesis at Yale University. The program is overseen by a Director, Dr. Jorge Galán, and an executive
committee of 5 Faculty members. The administrative entity of this training program is housed in the
Department of Microbial Pathogenesis at the Yale School of Medicine. Forty-four faculty members from
departments of the Yale Medical School and the Faculty of Arts and Sciences representing a cross-section of
the microbial pathogenesis research community at Yale are involved in the program as trainers. The training
Faculty carry out research in a broad range of topics that are directly relevant to microbial pathogenesis giving
students unique opportunities to explore different aspects microbial pathogenesis research. Trainees are also
provided with multiple opportunities for scientific interactions not only within their home Departments but also
throughout Yale University. The goal of this program is to train students in multidisciplinary approaches to the
study of microbial pathogenesis. The training faculty shares the view that the understanding of the biology of
pathogenic microorganisms requires experimental approaches and concepts from different fields of science.
Therefore the program seeks to provide students with the necessary broad experimental skills and knowledge
that will prepare them for a future research career in the study of microbial pathogens. The existence of very
strong basic science departments committed to this concept creates a unique environment in which this
training program can flourish and produce superbly trained scientists. The training program has been
strengthened by the addition of several new Faculty trainers and courses to cover emerging critical areas of
microbial pathogenesis research. The expansion of the Microbial Science Institute at the newly developed Yale
University's West Campus has enhanced the training opportunities for the students enlisted to this program.
The training program consists of formal course work and laboratory rotations during the first two years.
This provides a solid and broad conceptual foundation and knowledge base as well as broad experimental
training through the laboratory rotations. Students select a research advisor during the second year and
prepare and defend a research proposal that will serve as the foundation for the dissertation research project.
A Thesis committee monitors the student progress throughout the thesis research process and, finally, the
preparation of the dissertation. An External Advisory Board composed of highly accomplished scientists in the
field of Microbial Pathogenesis has been appointed to monitor the progress of this training program.
Students enter the program through the Combined Program in Biological and Biomedical Sciences
(BBS). The BBS unites the more than 250 faculty in basic biological and biomedical sciences at the Yale
Medical School, Science Hill on the main University Campus, and the newly developed West Campus.
Admission is granted to students with outstanding academic record with particular attention to research
experience. The training Faculty is strongly committed to a diverse student body, reflected in the historic
success of this program in the recruitment of students from under represented minorities. A robust program to
facilitate these recruitment efforts is in place, facilitated by strong institutional commitment to increase diversity
both in the student body and the Faculty at Yale University. Given the quality and depth of our pool of
applicants, and the expansion of the training opportunities, we request funds to support 4 graduate students in
years 2 and 3 (8 slots) for a five-year period.

Public health relevance
PROJECT NARRATIVE The Pre-doctoral Training in Microbial Pathogenesis at Yale University supports the education and training of the next generation of research scientists in microbial pathogenesis. Graduates from this program go on to leading positions in universities, research institutes, and industry, where they contribute to finding new approaches to prevent and combat infectious diseases.